Multimodal brain imaging of the neural effects of methylphenidate in patients with ADHD

There is continued interest to develop novel pharmacological treatments for attention deficit
hyperactivity disorder (ADHD), in part because of its high prevalence in the community, and lack
of optimal response to current medications, including intolerable side effects. Central nervous
system (CNS) pharmacodynamic (PD) measures have not been well characterized in pediatric
and adolescent populations, which is important for future drug development. Brain imaging tools
are ideal CNS PD measures in children because they are non-invasive and reproducible. Our
goal is to understand the neural correlates of treating ADHD with methylphenidate, specifically
in children and adolescents. First, we propose to determine the dose-dependent changes in
cognitive task-related neural activity after acute methylphenidate using functional magnetic
resonance imaging (fMRI, Aim 1). Then we will identify the changes in brain glutamate and
other brain metabolites after acute methylphenidate using high-field strength magnetic
resonance spectroscopy (MRS), and determine if these changes in brain chemistry correlate
with changes in brain function (Aim 2). Data from this study will shed light onto the
pathophysiology of the cognitive symptoms of ADHD and the neural response to treatment with
stimulants, which will guide future development of novel treatments and could serve as CNS PD
measures in future treatment trials. Furthermore, we will determine the utility of these CNS PD
measures in children and adolescents that will lay the groundwork for developing pediatric brain
imaging measures for other drugs and other CNS disorders.

Public health relevance
The goal of this proposal is to develop brain imaging tools to measure the effects of methylphenidate in children and adolescents with ADHD. Specifically, we will correlate brain activity during cognitive tasks and brain chemistry with cognitive performance. These measures could then be used to develop novel drugs to treat ADHD in children and adolescents.